GROWTH HORMONE DETERMINATION IN ACROMEGALY VIA BLOOD SAMPLING IN SLEEP

The purpose of this clinical trial is to assess the growth hormone pattern of patients diagnosed with acromegaly by obtaining serial blood sampling over an eight-hour period; to examine the sleep pattern and stages of sleep these patients experience at the time of blood sampling; and to analyse these patterns in light of patient diagnosis.